Outreach Core

PROJECT SUMMARY: OUTREACH (This core is identical to all three partnering institutions)
The overall goal of the Outreach Core is to implement and evaluate an evidence-based, theory-informed, multi-
level, clinical trial and cancer genomics education program (CTC-GEP) that addresses the determinants for
African American (AA) and Latinx participation in clinical trials and cancer genomics studies. The CTC-GEP is
informed by the Increasing Minority Participation in Clinical Trials (IMPaCT) program, an efficacious clinical trials
navigator program implemented at the University of Alabama at Birmingham O’Neal Comprehensive Cancer
Center. We will build on the findings of this program and extend application of the patient navigation model to
participation in clinical trials and genomic cancer research. A cadre of lay community navigator professionals
will be trained and serve as clinical trials navigators (CCN) to deliver two unique types of toolkits comprised of
evidence-based educational resources on research participation (low-tech) and culturally tailored educational
and multiple media content via mobile tablet technology (high-tech). The CCNs will deliver these toolkits and
provide logistical support to participants interested in participating in cancer research in rural and urban
community health and academic research centers within the Partnership catchment areas. The CTC-GEP will
also address AA and Latinx beliefs, values, attitudes, concerns, and preferences related to participation in
research, such as privacy, trust, and safety. An evaluation plan based on a logic model will be applied throughout
the project. Outcome measures will be assessed through pre- and post- surveys. The outcomes of the CTC-
GEP include a) intentions to participate in research, b) awareness and knowledge about research, and c)
genomic research and clinical trial enrollment. Additionally, having a Joint Clinical and Biomedical Research
Advisory Roundtable (JCAR) guided, clinical community navigation and education program will lead to increased
awareness, opportunity and participation in genomic research and clinical trials among a diverse population of
AAs and Latinx. The rationale for this Core, intended to facilitate research and not conduct research, is to identify
effective strategies to facilitate research participation among AA and Latinx populations. Thus, the activities
outlined in this proposal are congruent with the strategies in the Comprehensive Partnerships to Advance Cancer
Health Equity (CPACHE) RFA listed for the Outreach Core.